Manipulating N-acetyl-L-aspartate transport to treat Canavan leukodystrophy

Canavan disease is a vacuolar (“spongiform”) leukodystrophy caused by ASPA mutations that
diminish brain aspartoacylase activity. Current treatments for this neurodegenerative disorder,
which include dietary manipulations, administration of lithium citrate and anticonvulsants, and
AAV-mediated brain parenchymal ASPA gene therapy, do not reverse or prevent progression of
neurological deficits in affected infants and children.
Because aspartoacylase is necessary for cleavage of the abundant brain amino acid N-acetyl-L-
aspartate (NAA), brain NAA is markedly elevated in Canavan disease. We were the first to report
that knocking out or knocking down Nat8l, the gene that encodes the NAA-synthesizing enzyme
N-acetytransferase 8-like, prevented development of motor deficits and brain vacuolation by
aspartoacylase-deficient Canavan disease (“CD”) mice. Later, we showed that intrathecal
administration of an Nat8l-inhibiting antisense oligonucleotide to young adult CD mice reversed
their established brain NAA elevation, motor deficits and brain vacuolation. Together, those
results strongly support the hypothesis that motor deficits and brain vacuolation in Canavan
disease are consequences of elevated brain NAA.
Our most recent studies, presented in this grant application, indicate that constitutive deletion of
Slc13a3, which encodes NaDC3, a plasma membrane sodium-coupled transporter for NAA and
other dicarboxylates, normalizes brain NAA content and prevents ataxia and brain vacuolation in
CD mice. Also, we have confirmed prior reports that astroglia and renal proximal tubular
epithelium express Slc13a3 and NaDC3, and have localized meningeal NaDC3 expression to
arachnoid mater-associated Prox1+ cells.
We now plan conditional deletion studies to determine whether selective ablation of NaDC3 from
astroglia (Specific Aim 1), arachnoid (Specific Aim 2), or renal proximal tubular epithelium
(Specific Aim 3) is sufficient to normalize brain NAA content and reverse motor deficits and brain
vacuolation in symptomatic CD mice. Results of these studies will serve to guide development of
selective Slc13a3 and NaDC3 therapeutic targeting strategies for infants and children with
Canavan disease.

Public health relevance
Our preliminary data indicate that constitutive deletion of Slc13a3, the gene encoding NaDC3, a plasma membrane sodium-coupled transporter for N-acetyl-L-aspartate (NAA) and other dicarboxylates, prevents brain NAA over-accumulation, motor deficits, and brain vacuolation from developing in aspartoacylase-deficient Canavan disease (CD) mice. As an important step toward safe SLC13A3/NaDC3 targeting-based strategies for infants and children with Canavan disease, we will now test whether selective ablation in CD mice of astroglial, arachnoidal, or renal proximal tubular Slc13a3 is sufficient to reverse pre-existing brain NAA elevation, motor deficits, and brain vacuolation.